Climate impact on coastal ecosystem methylmercury: human exposure implications

DESCRIPTION (provided by applicant) Mercury (Hg) is the third most important contaminant on the CERCLA Priority List of Hazardous Substances (2011) and its organic and toxic form, methyl mercury (MeHg), is a potent toxin with human health effects. Marine fisheries particularly in coastal ecosystems are dominant sources of human exposure to MeHg through consumption of marine fish and shellfish. 48 states in the U.S. have issued advisories against consumption of fish due to MeHg, including coastal advisories for the Atlantic Coast and the Gulf of Mexico. Sub-populations most at risk for exposure include pregnant women and children and subsistence fishers. To date, research on MeHg fate has not investigated the interaction of climate change variables such as temperature and nutrient/carbon loading even though they are likely to have synergistic effects on the formation and transfer of MeHg to the fish and shellfish that humans consume. The investigators therefore propose to examine in detail individual and combined effects of these factors using laboratory and field studies, and through integrative modeling to examine their overall impact on human exposure to MeHg. The following three aims are the basis for their primary hypotheses: Aim 1: Determine the effects of temperature, nutrient and carbon loading on the net MeHg formation in sediments and the associated net inputs of MeHg to the water column in coastal ecosystems. Aim 2: Determine the interactive effects of temperature and nutrient supply/ecosystem eutrophication on bioaccumulation of MeHg by primary producers, and transfer between primary and secondary consumers in estuarine food webs. Aim 3: Predict how climate-induced changes in MeHg bioaccumulation in coastal food webs will increase exposure and risk to sensitive populations. The investigators will apply innovative experimental and field techniques to investigate the interactions between these factors on MeHg fate in estuaries. They will investigate sites in northern and southern latitudes to determine the influence of a natural range of temperatures on MeHg production and bioaccumulation in estuarine ecosystems. Finally, they will use experimental and field data to adapt and parameterize an existing MeHg biogeochemistry and bioaccumulation model to include variation in temperature and nutrient/carbon loading. These tools will allow them to predict the effects of climate change variables on MeHg production and transfer to fish to estimate the net effect of these changes on human exposure.

Public health relevance
Public Health Relevance: Methyl mercury (MeHg) is a global toxin impacting human health, and marine ecosystems are dominant sources of human exposure through consumption of marine fish and shellfish. Estuarine ecosystems are both a major source of MeHg to marine food webs and locations where climate induced changes and nutrient and carbon loading will have complex effects on the production, transfer, and bioaccumulation of MeHg. The investigators will examine these interactive effects which are critical to understanding the future impact of MeHg on human exposure and health. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The goals of this proposed research are to use experimental approaches, field studies, and modeling to investigate the interactive effects of changes in temperature and nutrient loading/carbon content associated with climate on the fate of MeHg in marine ecosystems. The research will focus on MeHg production, input to the water column, bioaccumulation in coastal food webs, and ultimately impact on human exposure to MeHg. Experimentally parameterized, field validated models are necessary to understand the impact of complex climate change induced alterations on MeHg fate and bioaccumulation in marine ecosystems. The Specific Aims and related hypotheses of the project are as follows: Aim 1: Determine the effects of temperature, nutrient and carbon loading on the net MeHg formation in sediments and the associated net inputs of MeHg to the water column in coastal ecosystems. H1: Temperature and carbon loading to sediments will interact to synergistically influence MeHg production, and flux from sediments to the water column. a. Increases in temperature and decreases in sediment carbon content will increase net Hg methylation and %MeHg in estuarine sediments, b. Increased eutrophication will result in a decreased input of MeHg from sediments to the water column because changes in sediment redox status will impact both the diffusive and advective fluxes from sediments as well as bioturbation and sediment resuspension. H2. In estuarine field sites spanning a range of comparable OM and Hg inputs, Hg methylation rates and %MeHg in sediments from southern latitudes will be higher than those from more northern latitudes. Aim 2: Determine the interactive efects of temperature and nutrient suply/ecosystem eutrophication on bioaccumulation of MeHg by primary producers, and transfer between primary and secondary consumers in estuarine food webs. H1.Temperatures and nutrient concentrations will impact bioaccumulation of MeHg by phytoplankton due to biomass dilution. H2. Temperature and food availability will impact bioaccumulation of MeHg by primary and secondary consumers. H3. In estuarine field sites spanning a range of comparable nutrient and Hg inputs, MeHg bioaccumulation will be higher in estuarine sites in southern latitudes than in northern latitudes. Aim 3: Predict how climate-induced changes in MeHg bioaccumulation in coastal food webs will increase exposure and risk to sensitive populations. H1: Temperature and nutrient/carbon enrichment in estuaries will alter MeHg production, transfer to the water column, and bioaccumulation in fish and result in changes in MeHg exposure to humans. Expected Outcomes: The field and laboratory studies under Aims 1 and 2 will test our hypotheses on how temperature and carbon/nutrients impact net methylation in sediments, its transfer to the water column, and bioaccumulation in the estuarine food webs. These approaches will yield a matrix of data that will be used to develop and parameterize a Hg ecosystem model which will be linked to a Hg exposure model. Human exposure under different temperature and nutrient/carbon loading conditions will be estimated based upon various fish consumption scenarios. We anticipate that these models wil be able to capture complex changes in each stage of MeHg fate and also capture the synergistic interactions that may result in changes in fish MeHg and overall impact on human exposure. The models wil also provide a mechanism through sensitivity analysis for testing the strength of each variable alone to determine it's relative importance in the predicted changes. Results from all three aims will be written up in manuscripts for publication in the peer-reviewed literature and will be presented at national and international meetings. We expect our experimental results and the ecosystem and Hg exposure models will be of interest to coastal managers and state and federal agencies, and other stakeholders interested in addressing and mitigating the impacts of MeHg bioaccumulation into coastal fisheries.